Administration

RESPONSIBILITIES OF THE ADMINISTRATIVE CORE The Administrative Core will be responsible for the ongoing planning and co-ordination of the individual components of the partnership efforts and for the promotion of interactions and collaborations among the SDSU and UCSD staff. Briefly, this core will: • Coordinate and run meetings of the Executive Committee twice a month • Convene, coordinate, and support the Local Advisory Committee (LAC) and any new committees it may deem necessary • Convene, coordinate and support meetings of the two LAC subcommittees as described below • Manage day-to-day operation of the project • Facilitate interactions between both grants and contract's offices and project/program co-leaders • Administer the planning and evaluation and the development component • Maintain communication with leadership at their respective institutions • Organize and disseminate information about the EC, LAC and subcommittee meetings • Advertise and organize the selection of pilot and full projects and/or programs • Convene the annual PSC and LAC meeting to review project and program proposals • Monitor progress of projects and/or programs • Recommend projects and/or programs for termination if necessary • Coordinate communications and yearly meetings with the external advisory committee • Encourage and support active participation of SDSU and UCSD faculty and scientists in partnership activities